TAS::75 0843::TAS ACTION TO CONTROL CARDIOVASCULAR RISK IN DIABETES

To follow-up ACCORD-MIND participants to acquire an additional measure of brain structure from Magnetic Resonance Images (MRI) of the brain.